Mechanisms of host protection during infection via the mitochondrial unfolded protein response

Project Summary
Mitochondria multitask various functions such as generating vast amounts of cellular energy and regulating cell
survival. Owing to their numerous cellular functions, mitochondria are often targeted by pathogens as a means
to promote infection. Indeed, pathogenic microbes use various means to subvert mitochondrial function in order
to survive and establish residence in their new host environment. In response to this targeted attack,
mitochondria execute various mechanisms to counter the growing infection. This includes the activation of the
mitochondrial unfolded protein response (UPRmt), a stress signaling pathway that helps mitigate dysfunction to
mitochondria through transcriptional adaptation. The UPRmt stimulates mitochondrial recovery by promoting
mitochondrial proteostasis, reactive oxygen species detoxification, and metabolic adaptation, among others.
Critically, the UPRmt also elicits an innate immune response as an antimicrobial strategy to fight infection and
promote host survival. Consistently, loss of the UPRmt renders animals more susceptible to bacterial infection
while, conversely, priming animals prior to infection increases host survival times. The coupling of innate
immunity/antimicrobial defense with the UPRmt is intuitive when considering how often mitochondria are targeted
during infection. Here, we will continue to explore the fundamental question of how the UPRmt acts as a
host defense mechanism during infection. Our proposal will address three broad questions: What is the role
of diet and nutrient sensing in the regulation of the UPRmt during infection? How does microbial metabolism
impact the UPRmt and host survival during infection? What role does the UPRmt play in the mammalian immune
system to protect the host from infection? In addition to leveraging the powerful genetics of C. elegans to dissect
these intricate questions, we will implement mouse models of infection that, combined, will yield important new
and exciting insights into the UPRmt as a host antibacterial defense mechanism. Considering the significant rise
of infections by antibiotic resistant bacteria, new alternative clinical interventions may be necessary.
Understanding how the UPRmt provides protection during infection, therefore, will not only lead to conceptual
advances in the field of host-pathogen interactions, but may hold therapeutic value as well.

Public health relevance
Project Narrative The mitochondrial unfolded protein response mediates mitochondrial recovery during stress while also promoting an innate immune response to promote host survival during pathogen infection. The discoveries we will make in this proposal not only have implications to our fundamental understanding of host-pathogen interactions, but also bear clinical relevance in an era of antibiotic resistance and need for alternative therapeutic strategies.